Development of methods for multi-omic analysis of DNA methylation and chromatin architecture in single cells

Project Summary/Abstract
Chromatin organization and epigenomic modifications such as cytosine methylation play instrumental roles
in gene regulation during human development and in healthy and disease states. Although the genome is
nearly identical in each cell in the human body, chromatin conformation and cytosine DNA methylation are
highly dynamic across cell types and during development. Previous studies showed that chromatin looping
can be regulated by cytosine methylation. However, our current state of knowledge of the interactions
between chromatin organization and DNA methylation is built on analyzing cultured cells and bulk tissues.
The interaction between cell-­type specific chromatin looping and methylation in heterogeneous tissues
remain largely unexplored. This project will develop single-­cell multi-­omic methods to jointly analyze
chromatin conformation and cytosine methylation from the same cell. The methods will lead to high quality
cell-­type specific chromatin conformation maps of human tissue, and the analysis of the relationship
between chromatin conformation and cytosine methylation. If successful, the proposed methods will greatly
facilitate the study of gene regulation in complex human tissues and in heterogeneous diseases such as
cancer.

Public health relevance
Project Narrative The goal of the project is to develop methods to study the interaction between a type of chemical modification to DNA - cytosine methylation - and the three- dimensional organization of the human genome. Cytosine methylation and genome organization are two important mechanisms to control gene expression in healthy and diseased tissues. These methods will allow the generation of multi- dimensional DNA methylation and genome organization maps from single human cells.